Elevating Indigenous Wellbeing through Assets-Based Prevention Science (ELEVATE) Training Program

ABSTRACT
Indigenous peoples in the United States and worldwide face the starkest inequities in premature mortality of any
racial and ethnic group. In the United States, American Indian/ Alaska Native (AI/AN) Peoples have 2X higher
rates of suicide, 4X higher rates of alcohol induced deaths, and 1.6X higher drug overdose deaths compared to
the US general population. To effectively drive change in the staggering inequities, we need a scientific workforce
that better represents Indigenous peoples. To date, Indigenous and other diverse scholars are vastly
underrepresented in NIH funding, including fellowship and training grants. The parallel inequities in public health
education, training, and preventable cause mortality stem from historical and contemporary social and structural
determinants. The goal of the Elevating Indigenous Wellbeing through Assets-Based Prevention Science
(ELEVATE) Training Program is to train Indigenous and other diverse predoctoral scholars to become
leaders in health equity research and strengths-based multi-level prevention science, addressing
worsening inequities in mental- and behavioral-health-related premature mortality among Indigenous
Peoples. To accomplish this goal, we will provide rigorous training and high-quality mentorship in (1) Health
disparities/health equity research, (2) Developing and implementing multi-level prevention interventions, and (3)
Methods to design and analyze studies that evaluate multi-level prevention interventions. We will also provide
cross-cutting training in (4) Indigenous methodologies as a way to root this training and decolonizing approaches.
Trainees well benefit from the program’s interdisciplinary and team-based mentorship and training approach.
The ELEVATE program will he led by a team of Indigenous and allied leaders and leverage the vast resources
of the Johns Hopkins Blumberg School of Public Health, including the Center for Indigenous Health’s (CIH) 40+
year trust-relationships with Tribal Nations and growing number of Indigenous and allied faculty. Specifically, the
ELEVATE program will be housed in the Social and Behavioral Interventions program, but the 3 trainees per
year may also come from the Department of Mental Health or full-time students from the school wide Doctorate
of Public Health Program. Trainees well undertake a rigorous program of coursework in health equity, multilevel
prevention, and associated and Indigenous methodologies. A year-long seminar to discuss research in progress,
ongoing mentored research projects, and integrative activities will complement coursework. ELEVATE will
synergize with CIH’s NIDA-funded P50 National Center for Excellence, Community-Driven Indigenous Research,
Cultural Strengths & Leadership to Advance Equity in Drug Use Outcomes (CIRCLE). This proposed program
aligns directly with the goal of the ADVANCE Predoctoral T32, the cross-cutting themes for the Office of Disease
Prevention’s strategic plan, and would address key cross-cutting strategic priorities for NIDA, NIMH, and NIAAA.
There are currently no predoctoral training programs for Indigenous health. The ELEVATE program fills this gap
and will help build the next generation of Indigenous and other diverse prevention scientists.

Public health relevance
PROJECT NARRATIVE The Elevating Indigenous Wellbeing through Assets-Based Prevention Science (ELEVATE) Training Program seeks to address significant health inequities in premature mortality faced by Indigenous communities by equipping a new generation of scholars with specialized training in prevention science and health equity research. The ELEVATE program addresses key gaps in funding and training for Indigenous health and is aligned with NIH priorities related to addressing health disparities and building a robust and diverse public health scientific workforce. By focusing on the key mental and behavioral health drivers of early mortality, such as suicide and drug- and alcohol-related deaths, this initiative aims to nurture Indigenous and other diverse leadership in scientific research and shape a healthier future for these communities.